Fluorescent nucleoside analogues to advance RNA-centered therapeutics

Abstract
This research program seeks to create synthetically modified, fluorescent nucleosides and oligonucleotides and
apply them to (i) imaging the uptake and endosomal escape of therapeutic oligonucleotides and (ii) identifying
ligands that bind specifically to RNA targets and modulate biology. Nucleic acid-centered medicine is important
because it presents a new opportunity to treat diseases that have been challenging in traditional medicinal
chemistry. We seek to address three important problems in nucleic acids chemistry that will be enabling to RNA-
centered medicine. (1) When nucleic acid-based medicines, including antisense oligonucleotides (ASOs), short
interfering RNAs (siRNAs), and mRNA vaccines are delivered to cells, they are taken up in endosomes, from
which < 5% of these drugs escape and are active. (2) Targeting RNA directly with small molecules has
encountered problems with ligand promiscuity; there is a need for additional screening methods for selective
ligand discovery. (3) Synthetic methodologies available for making C-ribosides, which are valuable in medicinal
chemistry, chemical biology and to make fluorescent probes, are much harsher and more limited in scope than
those for making C-2′-deoxyribosides. To address these challenges, we propose the following research plans.
(1) We will create modified ASO and siRNA surrogates incorporating a pair of fluorescent ribonucleosides where
one serves as an environmentally insensitive reference and the second as a pH-responsive probe that will
differentiate endosomal from cytosolic pH. These modified ASOs and siRNAs will be used for live-cell imaging
of RNA uptake and quantification of endosomal escape. (2) We will apply fluorescent nucleoside analogues to
the creation of riboswitch and RNA hairpin constructs designed to detect ligand binding that is both specific and
effective for modulating biology. These will be useful for studying ligand binding to therapeutically relevant RNA
and for discovering new ligands in high-throughput screening. (3) We will develop new synthetic methods for
making C-ribonucleosides that will have broad utility in chemical biology and medicinal chemistry. Together,
these research directions aim to advance nucleic acids chemistry as applied to RNA-centered therapeutics.

Public health relevance
Narrative This research aims to create two new molecular probe technologies to advance RNA-based medicine. RNA- based medicine involves using RNA as a programmable drug molecule or using RNA as a drug target; both approaches offer hope to treat diseases that have been intractable to traditional medicinal chemistry. We will create fluorescent probes useful for measuring and improving the delivery of RNA-based drug molecules and we will develop new fluorescent-based approaches useful for discovering small molecules that can bind to RNA and serve as drug leads.